Retrieval, Reprocessing, Normalization and Sharing of Gene Expression and Lung Microbiome Data Sets to Facilitate AI/ML Analysis Studies of Bacterial Lung Infections

Not Required per FOA

Public health relevance
PROJECT NARRATIVE Our research, aimed at understanding how let-7b inhibits bacterial growth and biofilm formation, may lead to the identification of new therapeutic targets that can be manipulated to eliminate chronic P. aeruginosa lung infections in people with cystic fibrosis, chronic obstructive pulmonary disease, and pneumonia.